The AMPK/ULK1/p27Kip1 axis regulates autophagy and cell survival in aged satellite cells

a. Project summary/abstract:
Sarcopenia is the age-related loss in skeletal muscle mass and strength; it leads to a host of co-morbidities
including loss of physical function. One such perturbation in persons with sarcopenia is the diminished ability
to regenerate muscle after injury. Muscle stem cells, referred to as satellite cells, are required to activate,
proliferate and differentiate to regenerate muscle and restore physical function. Aged satellite cells are slower
to activate upon injury; susceptible to apoptosis; and less efficient in repairing injured muscle. The AMPK-
p27Kip pathway appears critical for successful transition from quiescence to entry into the cell cycle. Our
preliminary data identify perturbations in the AMPK-p27Kip pathway with advanced age. This award period
will investigate the role of the AMPK-p27Kip pathway in the phenotype of satellite cell aging in both human and
mouse models. In Aim1, we will test the hypothesis that activation of AMPK and its downstream target p27Kip
regulates the autophagy/apoptosis decision in aged satellite cells. We will use molecular assays to rescue the
functional loss of this pathway in aged cells and return proliferative capacity. In Aim 2, we will test the
hypothesis that exercise, a physiological inducer of AMPK and autophagy, stimulates the AMPK-p27Kip
pathway, thereby enhancing proliferation and metabolic function in aging murine and human satellite cells. In
Aim 3, we will test the hypothesis that rescuing activity of the AMPK-p27Kip pathway in aged satellite cells will
improve in vivo regenerative capacity by transplantation experiments in injured muscle of young and old mice.
Together, the experiments in this proposal will test the hypothesis that the AMPK- p27Kip pathway is impaired
in aging satellite cells; and the hypothesis that this impairment contributes to the delayed proliferation rate,
susceptibility to apoptosis, and reduced ability to regenerate muscle after injury. Key aspects of Dr. White’s
career enhancement will be: to learn how to coordinate clinical exercise trials; to train in methods of satellite
cell isolation and metabolic analysis, especially in the context of the aging organism. The training program will
entail dedicated internal and external scientific presentations; pertinent course work/workshops in stem cell
biology and aging; and intensive career mentorship to ensure progress toward independence. The research
and career development plan detailed in this proposal will be conducted with a team of outstanding mentors.
Dr. William E. Kraus, a professor at the Duke Medical School is an established expert in clinical exercise
studies and muscle/satellite cell biology; he will serve as the primary mentor. Dr. White will also have Drs.
Bruce Spiegelman, Amy Wagers and Ana Maria Cuervo as co-mentors; they will respectively enhance
training in cell metabolism; aging stem cell biology; and autophagy. The Duke School of Medicine
environment is ideal for the research and training activities outlined in this proposal. This award will provide
Dr. White with optimal training to ensure an outstanding start to his career as an independent investigator.

Public health relevance
b. Project Narrative The loss of muscle mass with aging, referred to as sarcopenia, is associated with reduced quality of life, lack of independence, metabolic dysfunction and increased morbidity. There is an immediate need for treatment options to prevent the development of sarcopenia and all associated disabilities. Improving muscle stem cell function is one target to improve muscle regeneration and subsequent mobility in aged individuals.